2011 Cardiac Arrhythmia Mechanisms Gordon Research Conference

DESCRIPTION (provided by applicant): Cardiac arrhythmias are a major cause of mortality and morbidity in the developed world. Yet, the mechanisms of deadly arrhythmias remain to be elucidated. The main goal of this biannual Gordon Research Conference is to explore the fundamental mechanisms of the most complex arrhythmias, including atrial and ventricular fibrillation. New approaches to diagnosis, treatment, and prevention of cardiac arrhythmias will require the use of highly sophisticated tools that combine multiple technologies including novel imaging modalities, genetics, molecular and structural biology, tissue engineering, immunochemistry, patch-clamping, optical and high density electrode mapping of electrical wave propagation, and computer modeling. This field is represented by outstanding investigators at the forefront of research and experts in molecular biology, cellular electrophysiology, biophysics, biomedical engineering, mathematical biology, systems biology and clinical cardiology. This conference provides a forum to interact and share ideas about the role of numerous factors in the mechanisms of complex cardiac arrhythmias and sudden cardiac death, towards the goal of developing novel therapeutics.

Public health relevance
Cardiac arrhythmias are a major cause of morbidity and mortality throughout the world. However, despite many years of research, understanding the mechanisms that underlie complex arrhythmias remains elusive, hampering development of improved therapies. The 2011 Gordon Research Conference (GRC) on Cardiac Arrhythmia Mechanisms, to be held February 13-18, 2011, in Galveston, TX, will provide a venue for international scientific discourse on the new discoveries of the mechanisms that underlie disturbances in cardiac rhythm and lethal arrhythmias, and the novel approaches to therapy and prevention.